CORE--MORPHOLOGY FACILITY

The Morphology Core has primarily provided electron microscopy on a priority basis to Cancer Center members. Consultation and basic training in other morphological techniques such as cell microinjection, video time-lapse microscopy, immunofluorescence labeling, photomicroscopy and confocal microscopy have also been provided. The Morphology Core has provided services to 66 members of the Cancer Center from fourteen programs in the past year. This represents an increase of 30% in Cancer Center member usage and an increased program participation of 47% since the last submittal . The aims of the Morphology Core are: To provide Cancer Center investigators cost-effective access to state-of-the-art equipment and training in methods for studies of cell and tissue morphology. To provide service by highly skilled technical personnel in electron and laser scanning confocal microscopy.